Enrichment Program

PROJECT SUMMARY
The Enrichment Program is a core resource that coordinates activities focused on increased resource sharing,
training, education and academic development that will attract and develop leaders and research programs
focused on advancing and enhancing nonmalignant hematology research. Our highly successful CIHD
Enrichment program provides both local as well as national outreach to investigators and trainees in areas of
nonmalignant hematology research. Our program is designed to coordinate opportunities for 1) Expertise
Sharing and Establishment of Collaborations, 2) Education, 3) Coordinating activities with Trainee Programs
(e.g. T32 and T35), 4) Disseminating information to the broader research community via web-based tools, 5)
Attending Core Workshops provided by Core directors and staff, 6) Academic Development through Visiting
Scholars/Rising Stars P&F symposiums and Postdoctoral/Student Exchanges and 7) National Web-based
Virtual Workshops/Educational Seminars. The Enrichment Program is highly linked with the CIHD-sponsored
Core facilities and P&F programs, both internal and external, providing a platform for P&F funded researchers
and trainees to gather, share ideas, establish collaborations and participate in workshops focused on learning
expertise associated with core facility utilization. Finally, our Enrichment Program offers unique opportunities to
local and national established and developing researcher to interact with experts in the field of nonmalignant
hematology, iron, heme and metal research, which provides necessary critical feedback on research projects,
approaches, data presentation, academic development as well as discussion and implementation of new
methodologies/core facilities to build and sustain the research goals of the national community.